Evaluating ADGRB3 as a tumor suppressor epigenetically silenced in WNT medulloblastoma

RESEARCH, MENTORING, AND CAREER DEVELOPMENT PLAN:
RESEARCH PLAN:
Project Summary/Abstract of Funded Parent Grant:
There is an urgent need to develop novel therapies for patients with medulloblastoma (MB), the most common
malignant central nervous system (CNS) tumor in children. Current treatments include surgery, radiotherapy,
and chemotherapy and result in 5-year survival rates of 40-90% depending on subtype. However, children suffer
important morbidity secondary to treatment, including neurological, intellectual and physical disabilities. The
overall purpose of the present project is to investigate the role of the ADGRB3 receptor in susceptibility of
cerebellar transformation, and explore new therapies for MB based on the related mechanisms. ADGRB3 is an
orphan seven transmembrane G protein-coupled receptor (GPCR) specifically expressed in the brain, and
belonging to the adhesion-type sub-family. Our new preliminary data show that ADGRB3 expression is
significantly reduced in patients with MBs of the WNT group, and the promoter is epigenetically silenced,
suggesting that ADGRB3 loss may facilitate WNT-MB formation. We present evidence for the involvement of
methylated CpG binding protein MBD2 and histone methyltransferase EZH2 in switch to a silent chromatin.
Moreover, we show that reactivation of ADGRB3 can reduce cell proliferation and tumor growth, supporting a
tumor suppressive role. To test this in the physiological setting, we generated ADGRB3 knockout (KO) mice,
which we plan to cross with mice expressing mutant b-catenin in neural progenitors of the rhombic lip and dorsal
brainstem, which are the cells of origin of WNT-MB. Based on these results, we hypothesize that ADGRB3 is a
tumor suppressor in the cerebellum and that restoration of its expression with epigenetic therapy may represent
a novel therapeutic intervention for children with WNT-MB. To test our hypothesis, we propose the following
aims: (i) identify and target the epigenetic mechanism(s) underlying ADGRB3 gene silencing in WNT-MB, (ii)
determine whether and how restoration of ADGRB3 expression can inhibit MB cell growth, oncogenic signaling
and tumorigenic properties, and (iii) determine whether loss of ADGRB3 gene expression in the background of
oncogenic Ctnnb1 activation predisposes mice to cerebellar transformation and MB tumor development. These
studies are important as they increase our knowledge about developmental neurobiology in the CNS, and may
lead to the development of novel therapeutic approaches for patients with medulloblastoma.

Public health relevance
PROJECT NARRATIVE This project studies the underlying mechanisms through which Wnt medulloblastoma develops. It uses cell culture of human cells and experimental models in animals to study the functional role of ADGRB3 silencing in medulloblastoma formation and how it can be reactivated to be used as a cancer therapeutic. Understanding this novel mechanism of ADGRB3 repression in the background of oncogenic b-catenin (Ctnnb1) gene activation can be exploited to devise novel anti-cancer therapeutic strategies that will benefit public health